Target specificity of human RNA-induced silencing complex

PROJECT SUMMARY
In eukaryotic cells, gene expression is regulated at multiple levels, including post-transcriptional gene
silencing, where microRNAs (miRNAs) bind to complementary target RNAs and cause translational repression.
Argonaute (AGO) proteins and miRNAs form RNA-induced silencing complexes (RISCs), the core players in
gene silencing. Humans have four AGO proteins, AGO1-4, which share a high sequence identity, and the
majority of miRNAs bound are common across all AGOs. Therefore, it has been thought that the four AGOs
work redundantly. Nevertheless, an increasing number of studies have found that each AGO has its unique
roles in various biological processes and diseases in addition to gene silencing. Although the interaction of all
four AGOs with miRNAs has been well characterized, little is known about how each RISC recognizes its target
RNAs. Elucidation of this recognition will provide insight into the unique roles of each AGO. Meanwhile,
characterization of RISC and target interactions will facilitate target prediction accuracy by improving prediction
algorithms, which will take account of not only the complementarity between guide and target but also the type
of AGO and target interaction. In this proposed study, we will pursue the following specific aims. In Aim 1, we
will use cryo-electron microscopy and X-ray crystallography to determine the structures of all four
homogenously purified RISCs with the same guide and target RNAs, which will provide insight into the
differences in target recognition by the four AGOs. In Aim 2, to clarify these differences, we recently developed
a novel SHAPE-based technique which allows us to visualize the conformational dynamics of target RNA bound
to RISC. The method will enable us to characterize this interaction within the RISC binding channel and its
periphery at a single-nucleotide resolution and can be expanded to understand how RISCs recognize guide-
binding sites buried within highly structured target RNAs. In Aim 3, we will first use mass spectrometry to identify
the unique protein binding partners of each AGO and their specific sites of interaction. Then, we will use tandem
immunoprecipitation, followed by RNA sequencing, to determine how the binding of these proteins influences
the target specificity of each AGO and directs their functionality towards alternative cellular events. The
outcome from this study will provide a solid foundation for fields beyond gene silencing and enable the
development of new strategies for higher accuracy guide-RNA drug design in therapeutic applications.

Public health relevance
NARRATIVE In humans, microRNAs bind to target messenger RNAs and prevent their translation into protein, thereby maintaining the integrity of gene expression. To this end, microRNAs need to be loaded into one of four human Argonaute proteins, but how these proteins recognize their specific target RNAs remains unclear. We will solve this question in our proposed experiments so that the outcome will contribute to the development of a cure for microRNA-mediated diseases.